2024 BTEC conference (5/14/24 to 5/17/24)

ABSTRACT/SUMMARY
Brain tumors (malignant and benign/non-malignant) affect approximately 25 persons per 100,000 people in the
United States annually. It is estimated that there were 1,323,121 people living with a central nervous system
tumor as of the end of 2019. The burden of these tumors is particularly large on children, adolescents and
young adults where brain tumors are among the top causes of cancer and sources of cancer death. With
improvements in treatment for several types of brain tumors, the proportion of this population that are long term
survivors is increasing. As a result, the experience and needs of survivors is increasingly relevant. The Brain
Tumor Epidemiology Consortium (BTEC) was initiated in 2003 to facilitate interactions among brain tumor
epidemiologists and clinicians. Since that date, BTEC has offered yearly meetings for its participants and
created working groups leading to the funding of several consortium projects. To help enhance participation
and increase accessibility of the conference to trainees and all participants, we offer a proposal to the NIH for
partial funding of the 2024 BTEC conference in Mainz, Germany entitled, “Evolving Epidemiology of Brain
Tumor Survivorship.” Our 2024 meeting will focus on brain tumor survivorship across the age spectrum, in
addition to our usual topics including improvements in predicting brain tumor risk and survival. The Mainz
conference follows the tradition of alternating between a North American and a non-North American site each
year.

Public health relevance
PROJECT NARRATIVE We propose a 2024 conference for brain tumor epidemiologists and clinicians that will focus on survivorship issues for brain tumor patients. This conference will facilitate collaborative interactions among epidemiologists and clinicians, support development of trainees, and provide educational opportunities for all attendees.